IA Egg Regulatory Program Standards

Project Summary
Our focus will be on maintaining our compliance with the Egg Regulatory Program Standards
(ERPS) and to improve our processes under the ERPS standards by developing policies and
procedures, strengthening collaborations, conducting outreach activities, and conducting
program self-assessment to maintain and improve conformance with the standards. We
intend to focus on 4 main areas to reach these goals.
The first area will be to ensure we maintain our full implementation by working closely with the
FDA for both planning and determination of regulatory activities to be taken. In addition, we will
undergo and respond to regular assessments to maintain our conformance to the standards.
The second area of focus will be on continuous improvement. Through the annual Face to
Face Meetings and attendance at other meetings, such as NERO, we will learn best practices
from other state regulatory agencies as well as sharing our own with them. By evaluation and
implementation of those best practices we should be able to continuously improve our program
and streamline our processes.
Thirdly, we will conduct outreach activities, with a focus on the smaller firms in our state. We
will discuss biosecurity and how to minimize the spread HPAI. These outreach activities will
occur at fairs, extension offices, and potentially at other agriculture agencies (FFA, 4H groups,
etc.)
Finally, we will continue to develop our auditing program. We currently have two qualified
auditors, and so anticipate that we will be able to do all required audits in-house by the end of
the 3 year period covered by this grant.
Meeting these combined goals will help the Commercial Feed and Fertilizer Bureau to protect
public health by having policies and procedures in place to maintain a high quality Egg
regulatory program.

Public health relevance
Project Narrative The dual focus will be to maintain our compliance with the Egg Regulatory Program Standards (ERPS) and to improve our processes under the ERPS standards at IDALS. This will require working with FDA closely to ensure inspections are conducted in such a way as to be sufficient to take regulatory action, and continuing to identify and address areas in compliance to the ERPS standards that could be improved. These activities will strengthen our efforts to reduce exposure to contaminated eggs, prevent foodborne illness, and will equip IDALS to provide high-quality inspections that FDA will be able to use for enforcement action and that will be consistent with FDA or other states inspection results.